Integrating multi-omics datasets to infer phenotype-specific driver genes, regulatory interactions and drug response

PROJECT SUMMARY
Alzheimer’s disease and its related dementias (ADRD) are a growing public health crisis with no known
cure. Alzheimer’s disease (AD) is the most common cause of dementia, expected to affect about 50
million people globally by 2050. Despite extensive efforts, no effective treatment has been established.
Recent efforts in drug development for AD have not advanced at the rate needed to discover new and
diverse therapy modalities for the disease. Furthermore, due to complexity of AD pathogenesis and co-
morbid conditions, combination drug therapy is essential for efficacious treatment for AD. As traditional
drug discovery takes 10-15 years and costs $2-3 billion, computational drug discovery approaches have
gained popularity in recent years. Particularly, repurposing existing approved drugs for new diseases
could circumvent the labor- and cost-intensive process of traditional drug discovery. The aim of this
project is to develop a novel machine learning method to integrate multi-modal drug, disease, and protein
datasets to prioritize FDA-approved drugs and their combinations for AD/ADRD. To represent the multi-
modal datasets and the multiple relationships between drugs, diseases, and targets, an attributed
multiplex heterogeneous graph will be constructed. Inspired from growing research on deep graph
representation learning methods, a novel deep learning architecture will be developed to learn node
representations in this complex graph. Using these node representations, a machine learning model will
be trained to rank drugs and their combinations based on their associations to AD and AD-related
pathogenic processes and pathways. Using attention mechanisms, the proposed machine learning
model will be interpretable. The expected outcome of this research is a ranked list of drug combinations
for AD/ADRD, with novel drug-target interactions related to AD/ADRD along with key features and
datasets that support these findings. The proposed project will complement the efforts of the parent award
the goal of which is to develop open-source integrative computational tools that perform secondary
analysis of publicly available multi-modal biological, clinical, and environmental exposure datasets to infer
context-specific regulatory interactions and modules, and to predict disease associated genes and
patient-specific drug response.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease and related dementias (ADRD) are a growing health crisis, with current global management costs over $350 billion and cases expected to grow to 14 million globally by 2050. Despite extensive efforts, there is no effective treatment for Alzheimer’s disease (AD) while developing new drugs is cost- and time-prohibitive. To address these challenges, the aim of this project is to develop a computational method based on graph representation learning to integrate publicly available massive datasets on drugs, diseases and proteins to identify repurposable FDA-approved drug combinations for AD/ADRD.